CAA, Tau and Neurodegeneration

Summary
Alzheimer's disease (AD), the most common form of dementia, is characterized by the extracellular deposition
of parenchymal β-amyloid (Aβ), intracellular accumulation of tau as neurofibrillary tangles (NFTs), neuronal
cell loss, and significant inflammation. Cerebral amyloid angiopathy (CAA), the accumulation of amyloid in
arterial walls, occurs in over 85% of AD cases, positioning CAA as one of the strongest vascular contributors to
age-related cognitive decline. CAA has been associated with an active immune response and perivascular
deposition of hyperphosphorylated tau; yet these three pathological entities have never been linked in relation
with cognitive decline. Our recent studies have contributed to understanding the pathogenesis of CAA and the
preponderant roles that tau, reactive astrocytes and the complement system could play in the synaptotoxicity
associated with vascular amyloid deposition. Considering that there is still no clear understanding of the
molecular and cellular mechanisms and targets that underlie the contribution of CAA to neurodegeneration and
dementia, the main hypothesis of this renewal is that in CAA, there is a distinct group of neurotoxic
C3+ reactive astrocytes which significantly contribute to disease pathogenesis. Moreover, we
propose that reducing tau expression in these astrocytes leads to neuroprotection by
downregulating the complement pathway, resulting in reduced glial reactivity and synaptic loss.
By introducing a series of biochemical, molecular, histological, electrophysiological, behavioral, imaging, and
transcriptomics-based strategies together with novel mouse models and human postmortem tissue, this proposal
will 1. evaluate the neuroprotective effect of blocking C3+ astrocytes conversion on CAA pathogenesis in vivo, 2.
test whether cell-specific ablation of Mapt rescues disease-associated phenotypes in a CAA model in vivo and 3.
determine whether reactive astrocytes associated with vascular amyloid are distinct from astrocytes associated
with parenchymal amyloid deposits in CAA/AD patients, by integrating spatial whole transcriptomic with single
nucleus RNA sequencing.
The proposed studies will continue providing a platform for the understanding the mechanism(s) contributing
to neurodegeneration associated with CAA. Information gained from these studies may lead to the development
of effective therapeutics not only for CAA and AD, but also for a number of neurodegenerative diseases
characterized by the vascular accumulation of amyloid peptides.

Public health relevance
Narrative Cerebral amyloid angiopathy (CAA), a common finding in over 90% of Alzheimer's disease (AD) cases, is characterized by the deposition of amyloid in the cerebrovascular compartment. This overlap between AD and vascular brain pathology in dementia has been difficult to separate, with AD and vascular dementia probably existing as a continuum of distinct but mechanistically related processes. The studies outlined in this proposal will allow us to dissect in detail the mechanisms by which CAA leads to cognitive decline and may identify novel therapeutic targets for CAA and AD.